Effectiveness of comprehensive ETE interventions in the dental setting

Abstract
New York City remains an important battleground in efforts to end the HIV epidemic (ETE) and many hospital
based dental practices draw patients from high HIV incidence and prevalence neighborhoods. The goal of this
project is to assess the acceptability, feasibility, and effectiveness of a bundle of evidence-based ETE
interventions in hospital based dental clinics followed by a robust implementation evaluation if early success is
realized. The proposed study will draw upon both structural information technology (IT) interventions, such as
electronic medical record (EMR) alerts to prompt HIV testing, tablet-based HIV risk assessments for
consideration of HIV pre-exposure prophylaxis (PrEP), and engagement dashboards to ensure or re-establish
care linkage. We will also explore variations in the structure of the dental care team that might facilitate uptake
and performance of comprehensive ETE activities. The proposed project is segmented into phases, commencing
with the UG3 that will assess the acceptability and feasibility of introducing the IT enhanced ETE intervention
bundle (testing, prevention, engagement) to a standard dental team versus care navigator augmented dental
team model (Aim 1). If both models meet pre-determined acceptability and feasibility thresholds, we will conduct
a comparative effectiveness study using a cluster randomized model at four sites in the UH3 to determine the
optimal model (Aim 2). The optimal model will then be advanced to a full implementation evaluation at six distinct
hospital dental service sites, four associated with New York Presbyterian Hospitals in Manhattan, Brooklyn and
Queens and two New York City Health and Hospitals facilities located in the Bronx (Aim 3). To our knowledge
no prior studies exist examining the potential of introducing a full suite of evidence-based ETE interventions into
the dental care environment with careful attention to acceptability, feasibility, effectiveness and the real-world
implementation challenges across multiple institutions. The successful introduction, maintenance and
sustainability of comprehensive and effective HIV ETE activities in dental practices would likely prove to be a
vital component of any successful ETE strategy.

Public health relevance
Project Narrative We seek a UG3/UH3 to develop, implement and test the best care delivery model for an information technology enhanced bundled intervention to address strategies to end the HIV epidemic in multiple and diverse dental settings. This study builds upon our experience in HIV treatment and prevention, implementation science in both dental medicine, HIV and community based programs, behavioral science and bioinformatics.